Elucidating the transcriptional network in p63 expressing mammary myoepithelium

DESCRIPTION (provided by applicant): The transcription factor Trp63 is a lineage-specific transcription factor that is highly expressed and plays an important role in epithelial-rich tissue. This is epitomized by the striking phenotype of the p63 knockout mice, which lack a mature stratified epidermis and exhibit a block in development of multiple ectodermal appendages such as mammary glands, hair and teeth. Remarkably, in perfect phenocopy of the mouse model, dominant mutations of the Trp63 gene are found in human disorders with various combinations of ectodermal dysplasia, orofacial clefting and limb malformations. Deciphering the underlying molecular mechanism by which p63 transcriptionally regulates developmental processes has proven to be quite challenging, in part, due to the existence of multiple p63 isoforms. However, recent studies have strongly suggested that ΔNp63 proteins are the dominant isoforms expressed in epithelial cells where they can function as potent transcriptional regulators, dictate stem/progenitor cell renewal and orchestrate the balance between proliferation and differentiation. Hence, there is an emerging need for identifying specific molecular targets of ΔNp63, particularly other developmentally regulated transcription factors, which act together with ΔNp63 in mediating some of the biological functions of p63. However our knowledge of how ΔNp63 fits into the global transcriptional circuitry of mammary glands is not well characterized. We have generated a novel allele of ΔNp63-GFP mice, where the expression of GFP is driven by ΔNp63-specific regulatory elements thus allowing prospective isolation of ΔNp63-enriched myoepithelial/basal populations. Furthermore, we have developed and successfully utilized ChIP-grade antibodies directed specifically to the ΔNp63 isoform. These valuable resources coupled with the powerful technology of next-generation sequencing will allow us to a) Perform ChIP using anti-ΔNp63 specific antibodies and deep sequencing (ChIP-seq) to identify relevant ΔNp63 targets sites in mammary glands at high resolution and deep coverage, b) Analyze the results obtained from the global ΔNp63-binding sites by comparing them against the existing p63-target database to identify key members of the ΔNp63-driven transcriptional circuitry in myoepithelial cells that are likely to be relevant for the biological function of mammary glands. Given the essential role of p63 in mammary gland development and its close association with breast cancer, the identification of a well-defined ΔNp63 regulatory program is a critical step in understanding the molecular mechanism of its function and in integrating ΔNp63 with existing regulatory networks. Our studies to probe the in vivo ΔNp63-regulated transcriptome in a specific and global fashion will provide novel insights into mechanisms of mammary gland development and differentiation that has not been possible before.

Public health relevance
The p53-family member, p63, is a critical regulator for controlling the balance between myoepithelial proliferation and differentiation and for masterminding cell lineage choices in mammary glands. Alterations in the biological activity of p63 are often found in human patients with developmental disorders and breast cancer. Thus it is important to understand the molecular details of how p63 regulates epithelial growth and what signaling pathways and specific target genes are regulated by this factor so as to develop better new therapies and cures.